Clinical and Translational Research Services Core

The Clinical and Translational Research Services (CTRS) Core of the University of Washington (UW)
Nutrition and Obesity Research Center (NORC) is dedicated to human studies and replaces the former Adipose
Tissue and Obesity Core. CTRS Core services can be subdivided into 3 broad categories: 1) Study
Implementation, 2) Imaging, and 3) Nutrition and Physical Activity. Study Implementation services encompass a
range of clinical research support including blood draws and sample processing, research nursing, research
study coordination, and biostatistical analyses. Imaging services include body composition assessment in
humans using dual x-ray absorptiometry (DXA), quantitation of hepatic and visceral fat by magnetic resonance
imaging (MRI), and specialized imaging using brain MRI to quantify hypothalamic gliosis. Nutrition and Physical
Activity services include menu design, food frequency questionnaires and dietary recalls, controlled feeding
studies, and exercise training and testing. Services primarily occur at a new Clinical Research Unit that was
created specifically to support clinical research in diabetes, obesity, nutrition, and metabolism and is located at
the UW Medicine Diabetes Institute’s combined clinical and research facility. Through a new collaborative
arrangement with the Fred Hutchinson Cancer Research Center that reduces cost and improves access for our
Affiliate Investigators, we also leverage a fully staffed nutrition kitchen for metabolic feeding studies and a
nationally-recognized nutrition assessment resource. In this way, the CTRS Core markedly enhances the clinical
and translational component of the UW NORC and serves the needs of clinical, translational, and epidemiologic
Affiliate Investigators across multiple institutions, schools, departments, and divisions within the large UW
system. Interdisciplinary collaborations amongst these researchers, collaborations with basic science
researchers, and utilization of other NORC Cores are common, and will be actively facilitated by the
development, and optimization of the CTRS Core. In sum, the newly created CTRS Core is well equipped to
meet the following Specific Aims: 1) To support members of the research base with cost-effective access to
state-of-the-art techniques and resources for nutrition- and obesity-related research in humans, 2) To advance
science by offering and optimizing specialized clinical and translational research services, and 3) To educate
members through training, consultation, and collaboration.